Preconception obesity treatment: maternal bariatric surgery and long-term child health outcomes

Project Summary/Abstract
Obesity prevalence has been steadily rising in the U.S. over the past three decades, including among pregnant
women, children, and minorities. Accumulating evidence links maternal obesity – particularly severe obesity –
to increased risk for obesity and other chronic diseases in their offspring. Moreover, intervention strategies
targeting the prenatal period have yielded disappointing results, shifting focus to the preconception period.
Utilization of bariatric surgery procedures have become more common, including among women of
childbearing age, as it achieves weight losses averaging between 20% and 30% of total body weight (roughly
3-4 times more effective than lifestyle interventions) and is sustained long-term (seven years and longer).
However, the risks and benefits of preconception weight loss by bariatric surgery to children are poorly
understood, particularly in the longer-term.
The overall goal of the proposed research is to determine if surgically-induced preconception weight loss can
reduce their offspring's long-term risk of obesity and obesity-related health. We will utilize information collected
from a large cohort (n=2120) of women with obesity who lost weight by bariatric surgery before becoming
pregnant and their children. We will compare weight and weight related health (size for gestational age, infant
weight gain, BMI through 6 years of age) in children of women who received bariatric surgery prior to
pregnancy to two control groups born to women who did not undergo bariatric surgery (n=21,200). The first
control group will be matched to the mother's pre-surgical BMI; the second control group will be matched to the
mother's pre-pregnancy BMI (after surgery). We will then determine the extent to which pregnancy conditions
(gestational diabetes mellitus, hypertensive disorders, anemia, gestational weight gain) mediate associations
between bariatric surgery and child outcomes. We will further examine if smaller size for gestational age – one
known risk following bariatric surgery – is associated with child outcomes similarly in children born to mothers
with and without bariatric surgery, and without and without pregnancy anemia.
Our large, unique dataset created by a consortium of Kaiser Permanente and Oregon Health & Science
University sites, will allow us to address these questions in a diverse study population, with representation of
racial and ethnic minority women at highest risk of severe obesity. Study findings will provide understanding of
the role of preconception weight loss on long-term child health outcomes, the specific influence of achieving
this weight loss by bariatric surgery on these outcomes, and guide future outcome studies that focus on
improving maternal preconception weight by lifestyle, medical, and surgical means.

Public health relevance
Narrative: Rising rates of obesity and its complications in pregnancy may be contributing to escalating risk of obesity and chronic disease in the next generation of children. Recent research has shifted obesity management priorities to preconception weight loss, for which bariatric surgery is becoming increasingly more common in women with severe obesity. Findings from this study will provide much-needed evidence about the benefits and risks of preconception maternal weight loss in general, and specifically by achieving this weight loss after bariatric surgery, on long-term childhood health.